Sex Differences in the Clinical Expression of Alzheimer's Disease Neuropathology and Their Underlying Biological Mechanisms

PROJECT SUMMARY/ABSTRACT
Sex differences in the risk of Alzheimer’s disease (AD) and AD pathology burden have been
extensively studied; however, little is known about how AD pathology burden relates to clinical symptoms in
women versus men. Evidence of a cognitive advantage in the preclinical stage of AD, yet a two-times steeper
cognitive decline thereafter indicate that the question of sex differences in the clinical manifestation of AD
pathology is an important one. These sex differences have clinical implications in that our established
thresholds for AD clinical and biological markers used to diagnose and track disease were typically generated
without consideration for sex disparities. If women are better able to maintain what our current cognitive
thresholds consider “normal” cognition until a more advanced pathology state than men, then diagnosis of MCI
could be delayed, thus limiting the opportunity for early intervention. We hypothesize that sex differences in the
clinical translation of AD pathology results from a sex-specific balance of brain-related resilience/risk factors
that change with disease stage. Our proposal is particularly innovative in that we will first characterize sex
differences in how AD pathology relates to clinical symptoms by disease stage and then examine its
neurobiological underpinnings and clinical implications.
We will leverage both in-vivo, longitudinal biomarker data from the Alzheimer’s Disease Neuroimaging
Initiative (ADNI) and prospective neuropathological data in brain tissue from multiple Alzheimer’s Disease
Research Centers (ADRCs). Given their strong ties to AD pathology and the sex differences that our earlier
data show, we will examine the brain resilience/risk mechanisms of (1) PET-measured brain glucose
metabolism, (2) NMDAR density, a marker of glutamate neurotransmission, and (3) translocator protein 18kDA
(TSPO) levels, a marker of microglial activation. Specifically, Aim 1 will utilize ADNI data to examine sex
differences in trajectories of cognitive function and their relationship to longitudinal variation in AD pathology
(Aβ and Tau) and brain metabolism by AD stage. In Aim 2, we will conduct in vitro autoradiography in
hippocampal and cortical brain tissue of 60 normal control, 60 mild cognitive impairment and 60 AD dementia
autopsy cases to determine sex differences in plaque, tangle, NMDAR and TSPO density and how they relate
to each other and to antemortem cognitive function in each of the three diagnostic groups. In Aim 3, we will
take action on these sex differences by generating sex-specific cut-scores for cognitive tests commonly used in
MCI/AD diagnostic criteria with the optimal balance of sensitivity/specificity in detecting the presence of
clinically-significant levels of AD biomarkers/pathology. The public health benefits of our project would be
significant in that by understanding and accounting for sex disparities in our clinical and biomarker approaches
to AD diagnosis, we will improve clinical and biomarker approaches to disease diagnosis and tracking in both
sexes and possibly identify sex-specific therapeutic targets.

Public health relevance
PROJECT NARRATIVE Despite sex differences in the clinical and biological profiles of Alzheimer’s disease with women showing a cognitive advantage yet greater Alzheimer’s pathology in early disease stages followed by a two-times steeper decline, sex is not considered in our current diagnostic methods. In this study, we will use both in-life biomarker and postmortem neuropathological data to determine how the clinical expression of AD pathology differs in women versus men and understand why these differences occur and how they impact disease diagnosis. By accounting for sex disparities in our current clinical diagnostic approaches, we can improve and tailor risk assessment and diagnostic methods to be optimal for each sex.